NICHD Neonatal Research Network

PROJECT SUMMARY/ABSTRACT
Advances in the care of preterm and term newborns continues to demonstrate progress. However, adverse
childhood outcomes following morbidities of prematurity (BPD, IVH, NEC and others) and conditions affecting
late preterm and term infants (HIE, PPHN, sepsis) remain excessively high. The overarching goal of the Brown
Neonatal Research Network (NRN) Center is to identify critical gaps that contribute to undesirable newborn
outcomes and expand the evidence base to guide treatment and management with exceptionally high-quality
clinical research. Our specific goals are to bring fresh innovation to the NRN in domains of novel biomarkers,
genomics, neurobehavior and imaging and apply these to the design of timely clinical trials. New trials need to
be rigorous and reproducible since the ultimate measure of impact is whether the results drive change in
clinical practice. To accomplish our goals, the Brown NRN Center has been invigorated with important
leadership transitions among our physician scientists and research coordinator. We anticipate that our new
investigators will provide an infusion of novel ideas and areas of expertise which will build upon our solid
foundation. The latter has been created by our current investigators who will remain active in the NRN and help
maintain our longstanding clinical and research practices. That includes meaningful contributions to the NRN
since 1991 in which Brown investigators have led multi-center trials, made substantial contributions to trial
development, and conducted trials well. Our clinical research productivity is also reflected in our ability to
perform high quality clinical trials outside the NRN framework and reflects a deep commitment to our academic
mission. The Brown NRN Center is based at a single center, Women & Infants Hospital of Rhode Island (WIH)
which functions as the hub of a well-organized perinatal region encompassing all of Rhode Island and
southeastern Massachusetts. WIH performs 80% of the deliveries in Rhode Island and through its Maternal
Fetal Medicine outreach, and maternal/neonatal transports, impacts close to 15,000 deliveries a year. The
Brown NRN Center has close links with our Maternal Fetal Medicine Unit Network (MFMU) colleagues and
have demonstrated the ability to perform secondary studies of a MFMU clinical trial across the two networks.
Our state-of-the-art Neonatal Intensive Care Unit has fully embraced a family-oriented approach to newborn
intensive care where research and clinical management are linked reflecting our strong culture of research.
Critical to the mission of the NRN and any regional center is a well-developed and effective follow-up program
since primary study outcomes are often assessed between 2-7 years of age. The Brown NRN Center uses
innovative programs such as Transition Home Plus to maintain relationships with families after discharge to
home while reducing hospitalization rates and costs. The Brown NRN Center has a comprehensive array of
clinical and research abilities to examine the mother-infant dyad and provide critical collaboration for the
conduct of rigorous, cutting edge, multi-center trials that are the goals of the NRN.

Public health relevance
PROJECT NARRATIVE The overarching goal of this application is to leverage the exceptional clinician-scientists, research infrastructure, NICU Follow-up Program and diverse patient population of the Women and Infants Hospital of Rhode Island (WIH) to make important contributions to the Neonatal Research Network (NRN). Our current application highlights the significant contributions we have made to improving the outcomes of critically ill newborns since we joined the Network in 1991, and important changes we have made to our program and team of investigators to best invigorate and innovate our site. We aim to perform rigorous, systematic, multicenter studies to expand the evidence base for treatment of preterm and term infants and look forward to collaborating and data sharing with a broad range of centers across the Unites States as we work towards achieving the shared goal of improving healthcare and outcomes for newborns.